The combined role of ARID1A loss and estrogen signaling in endometrial cancer

PROJECT SUMMARY
Endometrial cancer is the most common gynecological cancer in the United States and causes more than
12,500 deaths per year with rising incidence and mortality as well as declining 5-year survival rates. Type I
(endometrioid) tumors make up 85% of all endometrial cancer cases and the vast majority of these tumors
express estrogen receptor alpha (ER). Almost every major risk factor for endometrial cancer involves excess or
unopposed estrogen, indicating that estrogen signaling through ER is a critical driver of endometrial cancer
progression. Despite the clear importance of estrogen signaling in endometrial cancer, animal models indicate
that excess estrogens are not sufficient in isolation to cause endometrial cancer and 98% of human
endometrial tumors harbor at least one somatic mutation in a commonly mutated gene. ARID1A is one of those
commonly mutated genes, harboring mostly truncating mutations in the majority of endometrioid endometrial
tumors at a rate that is higher in endometrial cancer than any other cancer type. ARID1A is a member of the
canonical BAF nucleosome remodeling complex, a complex that interacts with ER based on the literature and
our data. The loss of ARID1A in endometrial cancer cells could have several effects on estrogen signaling and
gene regulation in general, including an increased importance of ARID1B or non-canonical BAF complex
variants. These changes may create distinct vulnerabilities in ARID1A altered estrogen-responsive endometrial
tumors. In this proposal, we will explore the molecular and phenotypic crosstalk between estrogen signaling
and ARID1A alterations while taking advantage of our unique resources, including purified complete BAF
complex and a collection of endometrial cancer and normal endometrial models.
• In specific aim 1, we will probe the biochemical consequences of ARID1A loss on BAF activity and
recruitment by ER.
• In specific aim 2, we will analyze the genome-wide gene regulation consequences of combined
ARID1A alterations and active estrogen signaling.
• In specific aim 3, we will look for unique vulnerabilities in ARID1A mutant and ER active endometrial
cancer cells using genetic and pharmaceutical approaches.
The successful completion of this project will greatly enhance our understanding of how ARID1A alterations
work together with estrogen signaling to promote endometrial cancer and has the potential to uncover novel
treatment strategies that are desperately needed for this disease.

Public health relevance
PROJECT NARRATIVE Estrogen signaling plays a critical role in the development of endometrial cancer; however, it may not be sufficient to drive tumor formation as endometrial cancer usually arises in the context of common mutations and excess estrogens. The goal of the project is to determine how ARID1A mutations, which are common in endometrial tumors, cooperate with estrogen signaling and explore novel treatment strategies for the majority of endometrial cancers, which have ARID1A alterations and active estrogen signaling.